Center for Immunological Interventions against Gonorrhea (CIIG)

Modified Project Summary/Abstract Section

SUMMARY
Over 82 million Neisseria gonorrhoeae (Ng) infections occur globally and gonorrhea ranks second among notifiable infections reported to the CDC. Ng has a major impact on reproductive health, the well-being of newborns, and the transmission of the human immunodeficiency virus. Control relies on safe-sex counseling and identification and treatment of infected individuals, the latter of which is seriously
challenged by the rapid evolution of antibiotic resistance in Ng. New interventions are needed to reduce
the number of infections and curb the spread of resistant strains. The overall goal of the Center for
Immunological Interventions against Gonorrhea (CIIG) is to advance a promising vaccine candidate
through further preclinical development and into clinical trials. This goal will be accomplished by three
Research Projects that are focused on developing i.) a combination meningococcal outer membrane
vesicle (OMV) vaccine (VesiVax® IAMs-OMV-NgAg) containing promising recombinant Ng antigens
using the VesiVax® liposome vaccine platform. The OMV portion of the vaccine is designed to induce
broader reactivity against Ng strains; co-delivery of selected adjuvants (IAMs) and intradermal
immunization through a patented microneedle patch will be optimized to induce robust protective
responses (Projects 1 and 3); ii.) a peptide/virus-like protein immunogen to augment the VesiVax® IAMs-OMV-NgAg vaccine by inducing epitope-targeted antibodies that increase Ng susceptibility to host
immune defenses by blocking mechanisms by which Ng to evades complement activation (Project 2).
Three collaborative Scientific Cores will support the projects by providing state-of-the art measurements
of immune responses (Core B), in vivo efficacy testing in mouse models of Ng reproductive tract infection (Core C), and centralized systems for data management, study design, data analysis, and pre-IND activities (Core D). An Administrative Core (Core A) will provide the infrastructure needed to facilitate communications between the CIIG and NIH, and coordinate teleconferences among the Project and Core Leaders to foster data exchange, internal peer review and intra-center collaborations. A standing Scientific Advisory Board will review scientific progress each year and determine which products will be advanced for further pre-clinical development. Pre-IND activities will begin in Year 4 under a regulatory strategy provided by Core D.

Public health relevance
Project Narrative Gonorrhea occurs at high incidence in the U.S. and is associated with a high global disease burden globally. Current public health control measures are seriously threatened by the spread of antibiotic resistant Neisseria gonorrhoeae strains and diminishing treatment options. The proposed Center of Excellence for Translational Research will develop new interventions for gonorrhea by advancing one or more promising gonorrhea vaccines towards further preclinical development and clinical trials.